GWAS ILLUMINA ONCOARRAY PLUS 20K CUSTOM BEADTYPES (AMOS) FOR NCI

NCI funded contract support for the NIH Center for Inherited Disease Research (CIDR). Contract tasks include providing high quality throughput genotyping and sequencing services to eligible investigators.